ANTITUMOR ACTIVITIES OF ANTIRECEPTOR ANTIBODIES

Monoclonal antibodies to hormone and factor receptors on human tumor cells will be used to inhibit the growth of these human tumors in athymic nude mice. The antibodies used will be those that have been found in vitro to act either as hormone agonists or antagonists.